Administrative Core - Core A

Project Summary/Abstract - Administrative Core:
The objective of the Administrative and Biostatistical Core (Core A) is to integrate the overall administration
and fiscal management of the Program Project. The preparation of summary materials, manuscripts submitted
for publication, presentations, and progress reports will be carried out by this core. The financial accounting
and coordination with university administration and communication with appropriate university and Holden
Comprehensive Cancer Center committees including policy and oversight committees will also be essential
functions. Planning and scheduling meetings of the Program Executive committee, the internal advisors, and
visits of external advisors will be coordinated by Core A. All P01 related travel of Project and Core Leaders will
also be handled by Core A. By centralizing the administrative integration of all the components of the P01 we
will enhance the function and interdisciplinary programmatic nature of the projects as well as the efficient
utilization of the cores. In addition, Dr. Brian Smith from the Holden Comprehensive Cancer will also provide a
centralized resource for statistical consultation and analysis to all projects and cores through Core A.

Public health relevance
Project Narrative - Administrative Core: The objective of the Administrative and Biostatical Core (Core A) is to integrate the overall administration and fiscal management of the PO1 as well as provide statistical support to all projects. The preparation of summary materials, manuscripts submitted for publications, presentations, and progress reports will also be carried out by this core as well as integration of all programmatic activities. The financial accounting and coordination with university administration and communication with appropriate University and Holden Comprehensive Cancer Center committees as well as planning and scheduling meetings of the Program Executive committee, the internal advisors, travel, and visits of external advisors will also be coordinated by Core A.